Communicating Narrative Concerns Entered by RNs (CONCERN)

PROJECT SUMMARY/ABSTRACT
The Communicating Narrative Concerns Entered by RNs (CONCERN) system is an expert-knowledge,
machine learning, predictive model (CONCERN-PM) that produces an early warning score (CONCERN-EWS)
and is implemented as clinical decision support (CONCERN-CDS) to alert nurses and physicians about
hospitalized patients who are at risk of decompensation. CONCERN-PM leverages nursing documentation
patterns as a proxy measure of nurses’ decisions to increase surveillance and related interventions which are
an indicator of nurse concern about hospitalized patients – a key early indicator of decompensation. This five-
site observational implementation study is a renewal to our successful National Institute for Nursing
Research (NINR) funded R01, in which we developed and evaluated the CONCERN (Communicating
Narrative Concerns Entered by RNs) predictive model and clinical decision support (CDS) for hospitalized
patients in a multi-site randomized controlled clinical trial, with interim results of a 27% reduced likelihood of
inpatient mortality for patients whose clinicians received the CONCERN CDS intervention versus those who
did not. CONCERN-CDS alerts clinicians that a patient is at risk 42 hours earlier than leading EWS1. In this
renewal R01, we will conduct a five-site observational implementation study to evaluate fairness and
population validity of the CONCERN-PM, ecological validity of the CONCERN-CDS, and explore the
contribution of caregiver generated data to the performance of the CONCERN-PM as the next phase in
our multi-site nursing data science and implementation science program. EWS are in broad use at health
systems nationally, however, we have identified a lack of research findings demonstrating external validity and
fairness in other leading EWS.2 We will leverage 5 diverse study sites to test fairness, population validity, and
ecological validity across rural, suburban, and urban settings. The evaluation will be informed by the RE-AIM
(Reach, Effectiveness, Adoption, Implementation and Maintenance) and CFIR (
Consolidated Framework for
Implementation Research)
implementation science frameworks. The specific aims of this R01 Renewal are to:
Aim 1. Translate the CONCERN-PM to 2 additional specialty patient populations (emergency department and
inpatient pediatrics) and with the addition of social determinants of health (SDOH) data to evaluate model
calibration and performance across different patient populations and health systems; Aim 2. Evaluate
CONCERN-CDS implementation across all adult inpatient units at 5 health systems, in inpatient pediatric units
at 3 health systems and in the emergency department at 2 health systems to understand health system and
patient population characteristics associated with a successful implementation using RE-AIM and CFIR
Frameworks, and Aim 3. Using a patient-centered design approach, explore the creation of a patient-facing
CONCERN-PM and CDS for caregivers of inpatient pediatric patients, to compare predictive model
performance with additional caregiver feedback to the clinician-only data-driven model.

Public health relevance
Project Narrative In this renewal R01, we will conduct an observational implementation study across 5 health systems to evaluate the fairness and generalizability of the CONCERN predictive model and clinical decision support intervention. We will also explore how CONCERN could leverage pediatric caregiver input in real-time to improve the CONCERN predictive model. In this project we will also research how social determinants of health data and census level data can improve the CONCERN model so that it contributes to more equitable care for patients.